Neurobiology and Behavioral Consequences of Peripheral Vestibular Synaptopathy andRehabilitation

This application to the Rehabilitation Research and Development Service includes a research plan to
comprehensively investigate the condition of peripheral vestibular hypofunction, how it manifests in vestibular-
related behaviors, and whether it is associated with the induction of synaptopathy in vestibular hair cells.
Enhanced knowledge of vestibular hypofunction is critically important for two primary reasons. First, it appears
to exhibit broad penetrance among US service personnel and veterans, largely because vestibular hypofunction
may be associated with traumatic brain injury. And second, there is strong evidence that many forms of
vestibular hypofunction may be associated with synaptopathies, for which rehabilitation strategies may be
particularly effective for treatment. Therefore, in view of the heightened risk factors to which US service
personnel may be exposed, research into diagnosis and treatment of vestibular hypofunction and the association
with synaptopathies has the potential for broad impact on the lives of our Veterans.
While investigations into cochlear hypofunction have provided a wealth of valuable information regarding
their etiology, diagnosis, and treatment, information regarding vestibular hypofunction is in a nascent state. A
recent investigation of aging mice has demonstrated that synaptopathies are a component of age-related
vestibular hypofunction, thereby demonstrating that synaptopathies impact all inner ear sensory epithelia.
Cochlear hypofunction and synaptopathies are also induced by mild aminoglycoside treatment, resulting in
similar signature dysfunction as demonstrated for synaptopathies induced by mild acoustic trauma. The
proposed research plan endeavors to comprehensively investigate vestibular hypofunction induced by low-dose
gentamicin in a well-established animal model of normal vestibular function, implementing direct
intraperilymphatic administration to precisely control the dose delivered to the labyrinth. Preliminary data
demonstrated that vestibular hypofunction results from conditions that leave the vestibular sensory epithelia
morphologically intact, a condition that parallels the findings in cochlear synaptopathy. The hypofunction is
represented by attenuated coherence between stimulus and response in the discharge of afferent neurons,
indicating compromise to signal-to-noise ratios and information transmission along vestibular afferent pathways.
With this evidence, we proposed four hypotheses and associated Aims. In Aim I we will establish the direct
association of vestibular hypofunction with changes in synapse density, under conditions of gentamicin
administration for which we have functional evidence of potential synaptopathy from metrics derived from single
neuron electrophysiology. Direct measures of synapse densities, assessed through quantitative
immunohistochemistry, will be directly correlated with afferent physiology by intracellular labeling of
physiologically characterized afferent neurons. The research under Aim II is directed toward the development
of dynamic head stabilometry, a behavioral test of that we propose provides a window into the form of
hypofunction we observe in afferent neuron recordings. We submit that this behavior test requires integration of
multimodal CNS circuits that are affected by the increase in sensory uncertainty concomitant with conditions of
synaptopathy. Through Aim III we will elucidate the dose-dependent outcomes of graded hypofunction, and
establish the temporal course of synaptopathy development. Aim IV is directed toward testing the efficacy of
using dynamic stabilometry as a training tool to improve head stabilization function and potentially provide
synaptic rehabilitation. In summary, this study represents a comprehensive effort to ameliorate conditions that
are likely to impact a large number of Veterans, and lay the groundwork for future therapies restoring synaptic
efficacy and the conditions that compromise the activity of Veterans and the US population.

Public health relevance
Inner ear hypofunction is characterized by subtle compromise without that escape detection by traditional measures of cochlear and vestibular function. They may be associated with loss of synaptic components within sensory structures, but occur without overt loss of sensory cells or neurons. These synaptopathies can be induced by mild ototoxicity resulting in the hypofunction and not complete loss of function. US service personnel and Veterans are exposed to various conditions representing risk factors for vestibular hypofunction, including jet fuel vapors and treatments with known ototoxic agents including aminoglycoside antibiotics. There is recent evidence indicating that it may be associated with dizziness secondary to traumatic brain injury. The proposed research plan represents a comprehensive investigation of peripheral vestibular hypofunction in an animal model through which direct cellular, electrophysiologic, and behavioral correlates will be obtained. In particular, we will test whether vestibular hypofunction is associated with loss of synaptic structures as has been found in the cochlea. Through this research will emerge a novel behavioral test of vestibular function that can be readily translated to the clinical vestibular evaluation, and be implemented as a rehabilitative tool. Hence, the outcomes of this investigation will serve as a foundation for diagnosis and therapy to improve alleviate functional decline.